Glial Mechanisms Governing the Removal and Repair of Degenerating Myelin

PROJECT SUMMARY
From the parent grant R01NS122800: Myelin has evolved to speed up, finely tune, and increase the metabolic
efficiency of electrical signal transmission in the brain. In numerous human diseases however, myelin
degenerates, ultimately resulting in devastating motor and cognitive impairment. Importantly, in order for tissue
repair to proceed after myelin damage has occurred, the many layers of compacted cell membrane that constitute
the myelin sheath must be rapidly and efficiently removed by resident phagocytic cells in the brain. Defective
removal of these debris has been implicated in a number of degenerative conditions, including but not limited to,
multiple sclerosis and aging, yet we know little about the cellular dynamics and molecular mechanisms governing
these processes. In order to study these critical cellular events and answer questions centered on which cell
populations are involved and what roles these different cell types play, we have developed advanced techniques
for imaging and manipulating these discrete events in the live animal over a wide range of temporal scales from
seconds to months. These techniques include intravital imaging of new combinations of fluorophore-based
multicolor transgenic labels of distinct populations of neurons and glia together with label-free imaging modalities
specific for compact myelin. In addition to these powerful labeling and optical imaging strategies, we have also
developed a new technique for targeted induction of single-cell death, which we have recently established as a
model of on-demand and titratable demyelination in the mouse cortical gray matter. Combining these techniques
now allows dynamic investigation of demyelination and remyelination in the context of targeted genetic
manipulations and animal models of human disease. Using these powerful tools this project will investigate three
central aims. First, there is increasing evidence that in addition to microglia, the primary phagocytes of the brain,
other resident glial cell types, namely astrocytes and NG2 glia, are also involved and play important roles in the
phagocytosis and repair process. We will determine the precise contribution of each glial cell type in the dynamic
detection and clearance of degenerating myelin debris. Next, we and others have shown the importance of
phosphatidylserine receptors in the efficient detection and clearance of dying neurons and other cells in different
organs. We will determine the role and consequences of both defective phagocytic receptors and debris
digestion signaling on the dynamic response by NG2 glia to cortical demyelination and the resulting remyelination
success and myelin patterning. Finally, there is evidence that neuronal activity and/or sensory experience can
modify remyelination, but less is known about the roles of neuronal activity on phagocytic function in the context
of demyelination. We will determine the consequences of bidirectional neuronal activity changes on the response
by phagocytic cells to single-cell demyelination. Ultimately, these studies will reveal which cells are involved in
myelin debris clearance, the role of major cell debris recognition pathways in successful clearance and repair,
and how neuronal activity and sensory experience modify the response of phagocytic glia to a demyelinating
event.

Public health relevance
PROJECT NARRATIVE In numerous human diseases the insulating layer around nerves in the brain, called myelin, is damaged and must be efficiently cleared before tissue repair can occur. We have developed advanced methodologies for inducing, manipulating and observing myelin degeneration and repair in the live brain in real time. Using these tools this project will investigate how myelin debris are dynamically cleared by resident glial cells and the consequences of defective clearance on tissue maintenance and myelin repair.